Tumor downstaging with small molecule therapeutics to enhance Uveal Melanoma metastasis eradication by B7-H3 CAR T cells

Project summary
Uveal Melanoma (UM) is a rare cancer with an incidence of 5 cases per million in the United States. Nearly half UM patients
develop isolated liver metastases due to the high tendency of UM cells to spread to the liver. No cure has been found for
patients with metastatic UM (mUM). Tebentafusp, is the only FDA-approved therapy for mUM. However, it has shown
modest improvements in terms of overall response and progression-free survival and its applicability is limited to only 40%
of mUM patients. The lack of effective treatment options for mUM has prompted us to design a novel combinatorial
immunotherapeutic strategy based on the use of Chimeric Antigen Receptor (CAR) T cells specifically redirected against
B7-H3. The latter has been selected as the target of our immunotherapeutic strategy, since it is highly expressed on UM cell
lines and mUM tumor tissue samples, but has a limited expression on normal tissues.
It is a general experience that CAR T cell-based immunotherapy is not effective in eradicating solid tumors both in
preclinical and clinical investigations. This result is likely caused by multiple mechanisms, among which the major role is
played by their use in hosts with high tumor load; the resulting unfavorable effector to target (E:T) ratio in the tumor
microenvironment has a negative impact on the antitumor activity of CAR T cells, as indicated by the results generated by
preclinical and clinical investigations. The information in the literature and our preliminary results have provided the
rationale to design a strategy which applies first a tumor debulking approach to reduce tumor load and then CAR T cell-
based immunotherapy to eradicate UM metastases. We will use the combination of trametinib, a mitogen-activated protein
kinase kinase inhibitor (MEKi) and of panobinostat, a histone deacetylase inhibitor (HDACi), since this combination has
been shown to induce marked regression of UM liver metastases in mice. Furthermore, this combination does not affect B7-
H3 expression by UM cells and the antitumor activity of B7-H3 CAR T cells. Therefore, after having shown that B7-H3
CAR T cells can recognize and eliminate UM cells surviving the treatment with the MEKi and HDACi combination, we
will investigate whether tumor debulking induced by the MEKi and HDACi combination can enhance the ability of B7-H3
CAR T cells to eradicate UM liver metastases in NSG mice. Since one major limitation of CAR T cell-based therapy is
represented by its potential toxicity and/or cytokine release syndrome, we have incorporated in our CAR construct an
inducible caspase 9 safety switch which allows rapid elimination of CAR T cells in case of unexpected toxicities.
If the results generated by our experiments are positive, they will have a major impact on the treatment of mUM.

Public health relevance
Project Narrative The main goal of this proposal is to develop an effective therapy for the treatment of metastatic uveal melanoma (mUM) which utilizes Chimeric Antigen Receptor (CAR) T cells as the effector mechanism. Since tumor burden plays a major role in the limited efficacy of CAR T cell immunotherapy with solid tumors, NSG mice with UM metastases in their liver will treated first with the combination of trametinib, a mitogen-activated protein kinase kinase inhibitor, and panobinostat, a histone deacetylase inhibitor, to downstage the tumors and then with iCas9.B7-H3 CAR T cells to eradicate the remaining UM liver metastases. Mice will be monitored for tumor volume and survival. The results generated by the experiments outlined in the proposed study have the potential to have a major impact on the treatment of metastatic UM.